Inherited Disease, Caregiving, and Social Networks

Our Caregiving Study has developed over three phases:

Phase 1: Pilot Study
In the first phase of the project, we completed a pilot study in collaboration with Dr. Sato Ashida at the University of Iowa. The pilot examined caregiving networks of families affected by Alzheimers Disease and Related Dementia (ADRD) and tested the CaRENet assessment tool (Caregiving Roles and Expectations within informal caregiving Networks). From this pilot study, we have shown the value of a multi-informant approach to capture the structure and makeup of caregiving social network systems and shown that social relationships can be both stressors and coping resources which have significant impact on caregiver wellbeing. During the current reporting period, this work has resulted in one publication demonstrating how prior history with ADRD results in variability in caregivers social support systems.

Phase 2: Cross-Sectional Study
In the Cross-Sectional phase of the study, we expanded our research to consider how caregiving experiences might differ according to the life stage, disease context, and disease stage faced by each caregiver and care recipient. As such, we partnered with colleagues who have established patient cohorts in the NIH Clinical Center, including 1) Inborn errors of metabolism, 2) Mitochondrial disorders, 3) CLN3 Batten disease, 4) Undiagnosed diseases, and 5) Other diagnoses. In each, patients require significant caregiving resources related to activities of daily living. Those enrolled in this research completed a survey and interview, and primary caregivers who visited the NIH Clinical Center were also asked to provide samples for biomarker assessment.

In total during this phase of the study, we successfully consented 501 individuals from 247 families involved in caregiving networks. Of those consented, 416 completed survey, 388 interview, and 185 provided biological samples. During the current reporting period, we published five papers on the following topics: 1) interactional caregiving characteristics (malfeasance, nonfeasance, uplift), 2) shared responsibility and network collaboration in caregiving (we-talk), 3) the impact of caregiving for children with genetically-linked conditions on the hypothalamic-pituitary-adrenal axis, 4) parent-reported caregiving roles of siblings of children with inborn errors of metabolism, and 5) stress, coping, and physical health in caregiving. Additionally, we currently have. Additionally, we currently have three manuscripts under review.

Phase 3: Longitudinal Study
Finally, we transitioned our Caregiving Study from a Cross-Sectional study design to Longitudinal. With this current phase of the study, we conduct surveys and interviews with participants over the course of several years, instead of just once. Participants are asked to complete annual assessments every year for five years and three short surveys (i.e., daily diary log assessments) throughout the course of each year, which will help us understand the day-to-day activities, stresses, and supports related to caregiving. Primary caregivers who visit the NIH Clinical Center are also asked to provide a blood sample for analysis.

In total, we have successfully consented 77 individuals from 59 families involved in caregiving networks. Of those consented, 63 have completed first-year surveys and 65 completed first-year interviews. Twenty participants have enrolled in a second year of the study; 18 completed second-year surveys and 14 completed second-year interviews. Additionally, 40 individuals completed first-year daily diary log assessments, and 1 individual completed second-year daily diary log assessments. Ten individuals provided first-year blood samples.